BLR&D Merit Review Research Career Scientist (RCS) Award (IK6)

Abstract:
Currently, therapeutic treatment with immune checkpoint inhibitors(ICI’s), such as α-CTLA4 and/or α-PD1, are
increasing survival rates (>50% four-year survival), particularly in highly mutated tumors. Moreover, combining ICIs
with therapies that target tumor oncogenes has been highly effective in some tumors.
Our hypothesis is that response to ICI therapy in immunologically “cold” tumors can be enhanced by combining ICIs
with therapies targeted to oncogenic drivers that also induce expression of key chemokines that recruit CD8+T cells
and DCs to the TME and shift tumor associated macrophages to an anti-tumor phenotype, and reduce the infiltration
by myeloid-derived suppressor cells. To test this hypothesis, we will utilize immune competent mouse models,
humanized mouse models bearing patient-derived xenograft (PDX), and organotypic cultures of human tumor co-
cultured with patient immune cells to determine if these specific precision medicine approaches to targeted therapies
enhance response to ICIs, and improve survival in mice.
We propose to advance therapeutic strategies for melanoma and breast cancer in four areas. There are two
approaches we will develop for melanoma studies: 1) Using immune competent BRAFV600E/PTEN-/-,
NRASQ61K,R/CDKN2a-/- or triple wild type mouse models, humanized PDX models and 3D organoids of human
melanoma tumors co-cultured with immune cells isolated from the patient, we will determine whether treatment with
either rigosertib (NRAS pathway inhibitor), CDK4/6 inhibitor +MDM2 antagonist combined with ICI therapy induces
tumor regression. Mechanisms for alterations in anti-tumor immune response will be determined. 2). Using CyTOF
and sc-NGS analysis we will characterize biopsy tissue and PBLs from melanoma patients who develop resistance
to immune checkpoint inhibitors, evaluate the expression of other checkpoint proteins as well as activation of new
driver mutations, and use these data to develop new strategies for treatment with other checkpoint inhibitors and
targeted therapies using our organoid culture model.
For our breast cancer studies: 1) We will treat tumors with AKT inhibitors plus paclitaxel in combination with ICI
therapies or prior to ICI treatment using immune competent mouse models, humanized PDX models, and organotypic
cultures of patient tumors co-cultured with patient immune cells; 2) We will examine the tumor growth in mice with
targeted deletion of CXCR2 or CXCR4 in tumor tissue or in specific immune cell populations with or without targeted
therapies and immune therapy. Where appropriate, CXCR2 and/or CXCR4 antagonists may be combined with the
targeted therapies to enhance response to ICI therapy.
Altogether these studies will provide key information for the design of new clinical trials I melanoma and breast cancer
with our clinical collaborators and inform mechanisms of resistance to ongoing therapies. Melanoma and breast
cancer can be major issues for our Veterans and development of improved therapeutic contributions that enhance
overall survival is of key importance.

Public health relevance
Melanoma is one of the fastest growing tumor types in the US and 1 in 8 women develop breast cancer (BC) in their lifetime. The melanoma epidemic is largely confined to older men, but there is a stark increase in melanoma incidence in young women with extensive sun exposure. The most significant risk factors for BC are gender and age. The advent of immune checkpoint inhibitor therapy has resulted in increased overall survival for around 60% of melanoma patients and is beginning to impact certain BC patients. However, treatments are needed for the patients who do not respond or stop responding to immune therapy. We propose to build on our longstanding expertise in the regulation of inflammatory mediators and mechanisms of tumorigenesis to develop new targeted therapeutic combinations for treatment of melanoma and BC that enhance the response to immune therapy and prolong survival of our Veterans who develop these cancers. The ongoing research in the Richmond laboratory is highly translational and should contribute to advancing new clinical trials.